RESPIRATORY SYNCYTIAL VIRUS IMMUNE GLOBULIN--CHILDREN AT RISK FOR RSV INFECTION

This study's hypothesis is that RSVIG-IV is safe and can prevent respiratory syncytial virus associated hospitalizations in young children when given monthly during the RSV season.